Enhancing the TCR-induced Response of HLA-E-restricted Regulatory CD8 T Cells to Promote Allograft Tolerance

Abstract
We pioneered a novel regulatory CD8 T subset (CD8 Treg) that promotes transplant tolerance by suppressing
pathogenic CD4 T cells. CD8 Tregs use semi-variant TCRs that allow the selective killing of alloreactive CD4 T
cells via recognizing the surface class-Ib MHC molecules (Qa-1 in mice and HLA-E in humans). These CD8
Tregs express distinctive co-signaling receptors, including inhibitory Killer Ig-like receptor (iKIR), a checkpoint
that constrains the uncontrolled response of CD8 Tregs. The overall goal of this project is to leverage the
expertise we gained through the study of mice CD8 Tregs to develop clinically relevant CD8 Treg
immunotherapy. Our central hypothesis is that HLA-E-binding superagonists and iKIR inhibitors can
selectively mobilize human CD8 Tregs and promote allograft tolerance. In Aim 1, I will exploit the semi-
variant nature of HLA-E-restricted TCRs to develop a tolerogenic superagonist that specifically stimulates CD8
Tregs. This will be achieved by defining a dominant TCR used by human CD8 Tregs and reconstructing this
TCR to screen for a potent inducer from a peptide-HLA-E presenting yeast library. Using a kidney transplant
recipient's PBMCs, I will validate the efficacy of selected superagonists inducing CD8 Treg cytotoxicity against
alloreactive CD4 T cells. In Aim 2, I will study the mechanism of iKIR controlling the CD8 Treg response. I will
analyze the phosphorylation status of TCR signaling molecules and examine the change in CD8 Treg effector
capacity upon blocking the iKIR, in vitro. To investigate the role of iKIR expressed by human CD8 Tregs in
vivo, I will use a novel humanized kidney organoid transplant model we established; I will analyze the
activation of CD8 Tregs, suppression of alloreactive CD4 T cells, and prolongation of kidney organoid allograft
survival when humanized hosts are treated with an iKIR-inhibiting antibody.
Successful completion of the project can transform therapeutic strategies to achieve tolerance by suggesting a
human CD8 Treg vaccine, CD8 Treg-specific checkpoints, and a novel humanized mice model that allows
studying CD8 Treg immunotherapy, in vivo. The K08 award is necessary and sufficient to advance my niche in
catalyzing preclinical discoveries into phase-1 trials and to pursue my long-term goal of developing clinically
relevant personalized tolerogenic therapies.

Public health relevance
Project Narrative The U.S. recently celebrated a million cases of solid organ transplantation, and more than four hundred thousand people are living with a functioning allograft. Despite this life-saving operation, a lack of effective tolerogenic therapeutics is a critical barrier to long-term allograft survival. This project seeks to develop novel strategies to promote allograft tolerance via targeted activation of HLA-E-restricted regulatory CD8 T cells.